TACTILE COMPUTER DISPLAY

Knowledge representation in our information age is not in a useful display for the visually impaired. The blind person is especially disadvantaged when pursuing a high level skill, and is required to learn from an ever- changing, expanding, dynamic technology driven culture. The blind scientist cannot scan large amounts of current published articles. A sighted person must read and describe the information. The goal of this research is to find a combination of piezoelectric materials and surface mount electronics that will, in a unique geometry, produce a reliable Large Tactile Computer Controlled Array. The tactile pin density must meet the National Library of Congress specification for Braille. An Array size of 25 lines x 40 characters/ line, 6 pins/character, could replace Braille books. A single prime mover will provide the up motion for all pins. A piezoelectric latch, each pin controlled by the computer, holds the pin up or releases the pin to follow the prime mover down. A Modular geometry combines the computer interface piezoelectric driver surface mount components with each tactile pin latch. The volume needed is included in a surface size of 10 x 13 inches, with a depth of several inches.